2025 Pittsburgh Lung Conference: The Science of Medicine: Developing the Next Generation of Physician Scientists

ABSTRACT
This application requests partial funding for the 2025 Pittsburgh Lung Conference (PILC) with specific focus for
on “The Science of Medicine: Developing the Next Generation of Physician Scientists” to be held on
September 18-19, 2025, University Club, Pittsburgh, PA. The PILC has been a leading meeting in
Pulmonary Medicine for more than 20 years. With a focus on the presentation of cutting-edge topics in clinical,
translational, and basic research, the PILC brings together leaders from institutions across the country and
internationally to participate in thematic discussion and foster collaboration. For 2025, we will specifically
focus the meeting on the Next Generation of Physician Scientist Leaders. A major focus of the conference is on
early career physician-scientist development and will incorporate presentations, networking events, and career
development workshops highlighting 8 important topics related to becoming a successful physician-scientist.
This will be combined with state of the art sessions on Precision Medicine, Artificial Intelligence and
Machine Learning, Harnessing the Immune System to Treat Disease, and Changing Patient Outcomes
through Implementation Science. Speakers will be medical professionals (MDs and MD-PhDs) who are
prominent physician scientists from leading academic institutions nationally and internationally. Each of the
four sessions will feature presentations from physician scientists trainee and early career faculty. We aim to
attract Ph.D trainees and investigators who are at the front lines of Science and Medicine to foster
interdisciplinary research. We propose the following Aims: (1) To promote the interaction of students, clinical
trainees, post-doctoral trainees, and early career faculty with established investigators. Selected travel
awards will be targeted to these participants. As we are one of the NHLBI R38 and T32 sites, we will connect
with other R38s and T32s to encourage participation of trainees and PIs. (2) To provide an inclusive,
collaborative environment for basic, translational, and clinical researchers to disseminate and discuss
recent cutting-edge scientific advances that impacts science and medicine. The organizers have
extensive experience in conference organization and physician scientist training that will ensure a successful
meeting to attract the top trainees and early faculty in the field focused on the main identified cross-
collaborative topics.

Public health relevance
NARRATIVE This application requests partial funding for the 2025 Pittsburgh International Lung Conference (PILC) on “The Science of Medicine: Developing the Next Generation of Physician Scientists” with a specific career development focus for trainees and early career investigators. The conference will also focus on four clinically relevant cutting- edge research involving diverse fields such as precision medicine, artificial intelligence, immunology in medicine, and patient outcomes research, representing both a timely and suitable topic for a multi-disciplinary conference on lung disease. The 2025 PILC will provide an inspiring and engaging platform for participants, especially next generation physician scientists, to present their work, network with faculty and engage in panel and workshop groups to discuss scientific advances, build collaboration and obtain important lessons on the profession.